DTI IMAGING OF CORPUS CALLOSUM IN IPSILATERAL HORIZONTAL GAZE PALSY AND

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. "DTI imaging of corpus callosum in ipsilateral horizontal gaze palsy and progressive scoliosis" Tracking transcallosal pathways in patients with IHGPPS